FITting noninvasive testing into Lynch syndrome colorectal cancer surveillance: a multicenter, prospective trial

PROJECT SUMMARY/ABSTRACT
Lynch syndrome (LS), the most common inherited cause of colorectal cancer (CRC) affecting ~1.2 million Amer-
icans, carries 3-8x higher lifetime CRC risk than the general population. Colonoscopy starting early in adulthood
and repeated yearly or biennially is the only recommended surveillance strategy which translates into ~25-50
lifetime colonoscopies. This intensive colonoscopy surveillance is not ideal because: a) CRC risk varies widely
by LS gene and age, b) colonoscopies are invasive, costly, and not readily accessible to all patients, and c)
adherence is suboptimal. Personalized surveillance strategies in LS that integrate non-invasive tests with colon-
oscopy would address limitations and barriers in current clinical practice but have not been previously studied.
To address these gaps, this multi-center, prospective trial will examine performance of fecal immunochemical
test (FIT) in LS patients undergoing colonoscopy surveillance. In addition to measuring FIT test characteristics
(specificity, sensitivity, negative and positive predictive value), this study will examine LS patients' attitudes and
acceptability of non-invasive tests (Aim 1). The proposal will evaluate personalized surveillance strategies in LS
that integrate non-invasive tests and colonoscopy using simulation modeling (Aim 2). An important deliverable
is the 1st well-annotated, prospective LS biobank in the US for future studies of promising biomarkers and clinical
outcomes (Aim 3). This study is timely because of the unique opportunity to harmonize data with the UK “FIT for
Lynch” study that began recruitment in 2023 in order to evaluate FIT performance in a large, international LS
cohort. Taken together, the proposal is significant because it has potential to change paradigms of CRC surveil-
lance in order to improve the lives and longevity of LS patients.

Public health relevance
PROJECT NARRATIVE This study addresses knowledge gaps in personalized colorectal cancer surveillance in Lynch syndrome (LS). A prospective trial will measure FIT performance in LS, and modeling will evaluate integration of non-invasive tests with colonoscopy for LS surveillance. A key deliverable will be the 1st prospective LS biobank in the US.